Mitochondrial pore and synaptic stress in Alzheimer's disease

Program Director/Principal Investigator: Du, Heng Project Description/Abstract Mitochondrial dysfunction and synaptic loss are early pathological features of Alzheimer's disease. Recent studies indicate that mitochondrial alterations in AD underlie Aβ-mediated synaptic pathology as evidenced by the observations: 1) significant correlation of mitochondrial dysfunction with synaptic loss in AD; and 2) the protection of mitochondria attenuates Aβ-induced synaptic changes. However, the mechanisms of Aβ-induced mitochondrial dysfunction and the consequent synaptic damages have not fully delineated. Notably, mitochondria in neurons are heterogeneous in their properties. A sub-group of neuronal mitochondria locating at synapses or namely synaptic mitochondria play a pivotal role in maintaining synaptic activity/function due to their physical proximity to synapses. Thus, to elucidate the mechanisms underlying Aβ-potentiated synaptic mitochondrial dysfunction is of great significance to deepen our understanding of the synaptic pathology in the pathogenesis of the AD. In the preliminary studies, we have demonstrated that synaptic mitochondria undergo increased propensity towards cyclophilin D (cypD)-mediated mitochondrial permeability transition pore (mPTP) in the Aβ milieu, transgenic AD mice overexpressing Aβ. Along with these changes, Aβ-insulted synaptic mitochondria underwent respiration defects. In addition, Aβ treatment resulted in decreased axonal mitochondrial density and the loss of synapses in cultured hippocampal neurons. As a contrast, these detrimental effects on synaptic mitochondrial and synaptic alterations were significantly attenuated by the blockade of cypD through genetic depletion of cypD.Thus, I have formulated a hypothesis that cypD-mediated mPTP is a potential mechanism underlying Aβ-induced synaptic mitochondrial dysfunction and synaptic alterations. To address this concept, I will utilize an AD mouse model (APP mice) and a novel genetically manipulated transgenic mouse model (genetic cypD-deficient APP mice) as well as cypD-deficiency hippocampal neuron cultures for the studies proposed in this application. This project contains three aims: 1). to determine the impact of cypD-mediated mPTP on synaptic mitochondrial function in APP mice; 2) to determine the impact of cypD-mediated mPTP on synaptic (axonal) mitochondrial dynamics and motility in Aβ milieus; and 3) to determine whether cypD-mediated synaptic mitochondrial dysfunction contributes to Aβ-induced synaptic alterations in APP mice. Upon the completion of this project, I will determine the involvement of cypD mediated mPTP in Aβ induced synaptic mitochondrial dysfunction, and the impact of cypD mediated mPTP on synaptic mitochondrial dynamics and motility, and synaptic function as well as animal learning/memory ability in APP/Aβ overexpressing mice. Finding derived from this study will have positive impact on the development of new therapeutic approaches for AD treatment. This project will also serve as a firm foundation of my scientific career to establish a research direction distinct from my mentors' by the combination of synaptic mitochondrial dysfunction and synaptic alterations in AD. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Project Narrative Cyclophilin D mediated mitochondrial permeability transition (mPT) is a deleterious factor that involves in mitochondrial pathology. This project will determine the involvement of cyclophilin D mediated mPT in synaptic mitochondrial dysfunction and the consequent synaptic degeneration in an Aβ rich environment. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page __SpecificAimsTextDelimiter__ Program Director/Principal Investigator: Du, Heng SPECIFIC AIMS: Mitochondrial dysfunction and synaptic loss are early pathological features of Alzheimer's disease [1-9]. Recent studies indicate that mitochondrial alterations in AD underlie Aβ-mediated synaptic pathology as evidenced by the observations: 1) significant correlation of mitochondrial dysfunction with synaptic loss in AD [10-12]; and 2) the protection of mitochondria attenuates Aβ-induced synaptic changes [2, 4]. However, the mechanisms of Aβ-induced mitochondrial dysfunction and the consequent synaptic damages have not fully delineated. Notably, mitochondria in neurons are heterogeneous in their properties [13, 14]. A sub-group of neuronal mitochondria locating at synapses or namely synaptic mitochondria play a pivotal role in maintaining synaptic activity/function due to their physical proximity to synapses [15-25]. Thus, to elucidate the mechanisms underlying Aβ-potentiated synaptic mitochondrial dysfunction is of great significance to deepen our understanding of the synaptic pathology in the pathogenesis of the AD. In our preliminary studies, we have demonstrated that synaptic mitochondria undergo increased propensity towards cyclophilin D (CypD)-mediated mitochondrial permeability transition pore (mPTP) in the Aβ milieu, transgenic AD mice overexpressing Aβ. Along with these changes, Aβ-insulted synaptic mitochondria underwent respiration defects. In addition, Aβ treatment resulted in decreased axonal mitochondrial density and the loss of synapses in cultured hippocampal neurons. As a contrast, these detrimental effects on synaptic mitochondrial and synaptic alterations were significantly attenuated by the blockade of CypD through genetic depletion of CypD.Thus, I have formulated a hypothesis that CypD-mediated mPTP is a potential mechanism underlying Aβ-induced synaptic mitochondrial dysfunction and synaptic alterations. To address this concept, I will utilize an AD mouse model (APP mice) and a novel genetically manipulated transgenic mouse model (genetic CypD-deficient APP mice) as well as CypD-deficiency hippocampal neuron cultures for the studies proposed in this application. Aim 1. To determine the impact of CypD-mediated mPTP on synaptic mitochondrial function in APP mice. In view of my observations that Aβ-rich synaptic mitochondria revealed a significant elevation of CypD expression levels and increased Ca2+-induced mitochondrial swelling, I hypothesize that CypD-potentiated mitochondrial permeability transition pore (mPTP) contributes to Aβ-induced mitochondrial dysfunction, in particular synaptic mitochondria. To test this concept, I will first examine synaptic mitochondrial properties, including membrane transition pore, from APP mice overexpressing Aβ and non-transgenic (nonTg) littermate controls to determine the effect of Aβ. Then, I will assess synaptic mitochondrial function in CypD-deficiency APP mice (APP/Ppif-/-) as compared to the single APP and nonTg mice to determine the effects of lack of CypD. The synaptic mitochondrial functional assay will include mitochondrial membrane potential, oxygen consumption, key enzyme activities, ATP levels, oxidative stress and synaptic mitochondrial Aβ levels. Aim 2. To determine the impact of CypD-mediated mPTP on synaptic (axonal) mitochondrial dynamics and motility in Aβ milieus. Normal synaptic mitochondrial mobility and dynamics are required for synaptic maintenance. Disruption of synaptic mitochondrial function could interfere with mitochondrial distribution and transport in axon and synapse [26-29]. Further, our preliminary studies demonstrated that neurons lacking CypD were resistant to Aβ-induced reduction of axonal mitochondrial density. Thus, it is essential and logical to validate the role of CypD in Aβ-induced synaptic/axonal mitochondrial dynamics, trafficking and distribution. We hypothesize that CypD is a key player in axonal mitochondrial motility and dynamics changes in response to Aβ. We will first examine expression levels of mitochondrial fusion and fission proteins and their translocation to synaptic mitochondria in Tg mice (APP, APP/Ppif-/-, nonTg, and Ppif-/-) at age of 4, 8, 12 ,and 20 months. Second, we will determine the direct effect of CypD and Aβ overproduction on hippocampal neurons cultured from APP, APP/Ppif-/-, nonTg, and Ppif-/- mice. We will evaluate mitochondrial distribution, morphology, and trafficking in axon, along with their mitochondrial function. Aim 3. To determine whether CypD-mediated synaptic mitochondrial dysfunction contributes to Aβ-induced synaptic alterations in APP mice. Synaptic mitochondria are vital for maintenance of synaptic function and transmission through normal mitochondrial energy metabolism, distribution and trafficking, and synaptic calcium modulation. Based on our preliminary studies showing the protection of CypD blockade in Aβ-induced synaptic loss in hippocampal culture neurons, I hypothesize that CypD-mediated synaptic mitochondrial stress through impaired mPTP and alterations of axonal mitochondrial trafficking/dynamixs underlies synaptic failure in Aβ-rich environment. We will analyze the effects of CypD depletion on 1) synaptic morphology (dendritic spine generation and maturation, spine density and type of spine); 2) synaptic transmission (pre- and post-synaptic activity) and long term plasticity; and 3) spatial learning and memory in vivoTg mice (APP, APP/Ppif-/-, nonTg, and Ppif-/-). The results of these studies will provide new insights into mechanisms underlying CypD/Aβ-mediated synaptic damages in Aβ-rich synaptic mitochondria of APP mice. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page